A multicenter, double-blind, randomized, placebo- controlled, parallel study to assess the efficacy of 5- HT4 agonist prucalopride for the treatment of diabetic and idiopathic gastroparesis

Abstract
In the clinical world of diagnosis and treatment options for the spectrum of gastroparesis (GP) symptoms, there
are still numerous and challenging needs to understand, while at the same time further investigating the
pathophysiology of this entity, which affects > 10 million of patients in the US. GP patients exhibit a range of
symptoms which do not always correlate with the objective tests we rely on for diagnosis, as well as for assessing
their clinical reactions to pharmacological agents.
Our response to the NIDDK Gastroparesis Consortium (U01) under RFA-DK-20-504 has the following aims:
1) A) Continue and complete already approved studies initiated by the GpCRC, which specifically entails
enrolling qualified patients to Gastroparesis Registry 3, with all relevant clinical and bio-samples, including
also PBMC isolation (peripheral blood mononuclear cells), as well as completing the Buspirone (BESST)
clinical trial; B) Continue obtaining gastric antral and pyloric smooth muscle tissue samples at the time of
surgeries to further advance our knowledge of pathological basis of gastroparesis (PBG) protocol. C)
Investigate Pyloric Sphincter Abnormalities in Patients with Gastroparesis Symptoms (PSAGS) per the
EndoFlip assessment protocol.
B) Our additional proposals for the GP Registry 4 (GpR4) are: 1) During the routine EGD for GpR4 and
possible PSAGS studies, we would like to collect samples of duodenal and gastric microbiota by obtaining
brushings of gastric and duodenal mucosa; 2) biopsy antral muscularis propria tissue using Endoscopic
Submucosal Dissection (ESD) methodology during upper GI endoscopy .
2) As a new research strategy, we propose to investigate whether microbiota obtained at the time of endoscopy
by brushing the mucosa of the stomach and duodenum, will differ in their composition in idiopathic and
diabetic GP and control patients. We hypothesize that dysbiosis of the upper GI microbiota may contribute
to the delayed gastric emptying and symptoms in GP patients, particularly in the idiopathic subgroup of our
cohort.
3) Our clinical trial proposal is to investigate the therapeutic efficacy of a new selective 5-HT4 receptor agonist,
Pruclalopride, to improve the symptoms and gastric emptying in idiopathic and diabetic GP patients while at
the same time having an excellent safety profile. A multicenter, double blind, randomized, placebo-
controlled, parallel study, will be conducted were all GpR4 patients from all centers will be invited to be
enroll into 2 parallel 4-week treatment periods with placebo or pruclalopride 2mg QD trial.

Public health relevance
Project Narrative Gastroparesis affects approximately 10% of the US population, with patients suffering with chronic, severe and difficult to control symptoms of nausea, vomiting, inability to finish normal size meal, fullness and abdominal pain. The NIH GpCRC has generated an extensive number of individual studies, which have increased our knowledge and concepts of understanding of this condition, its complications, diagnostic challenges and clinical outcomes. As the next step in the continuation of our research, we are proposing two new clinical projects: 1- Investigate whether the composition of the gut microbiota, in the stomach and duodenum of GP patients differs in idiopathic, compared to diabetic etiologies and control patients; and 2- investigate how a new medication, utilizing the mechanism of 5 Hydroxytryptamine (5HT) stimulation by a selective 5HT4 receptor agonist, which is already FDA approved for constipation, may help to reduce symptoms of gastroparesis as well as accelerate gastric emptying while having a satisfactory profile adverse event.